Evidence of neurogenesis in an adult mammalian retina initiated by an alpha7 nAChR agonist

In adult zebrafish, Müller glia are the source of new retinal neurons (57). While adult mammals also possess
Müller glial cells, they do not typically possess the same regenerative abilities found in zebrafish. However,
recently, this lab has provided evidence that Müller glia induce Müller glia-derived progenitor cells (MDPC) in
adult rodents. Specifically, eye drop treatment with the selective alpha7 nicotinic acetylcholine receptor (nAChR)
agonist, PNU-282987, has been shown to cause dedifferentiation of Müller glia and neurogenesis in the adult
rodent retina (15-19). This current R15 grant proposal is designed to test the hypothesis that PNU-282987-
induced neurogenesis of retinal neurons in adult mice occurs through indirect activation of Müller glia. Two
specific aims have been designed to address this hypothesis. The first specific aim is designed to quantify the
specific retinal cell populations that undergo mitosis and proliferation after application of PNU-282987 in the adult
mammalian retina using flow cytometry. Previous results from this lab demonstrated that eye drop application of
PNU-282987 induced neurogenesis of photoreceptors and RGCs that originated from Müller glia (19). Specific
aim #1 is designed to determine and quantify what specific retinal cell populations are affected by eye drop
application of PNU-282987 using flow cytometry. Does PNU-282987 induce neurogenesis in all retinal cells?
The Fortessa flow cytometer will be used to detect and count markers associated with various retinal cells, cell
components associated with progenitor cells, Müller glia and mitotically active markers before and after PNU-
282987 treatment. The second specific aim is designed to examine the transcriptome gene changes that occur
in primary cultures of Muller glia that lead to formation of progenitor cells after treatment with an alpha7 nAChR
agonist. In this proposal, primary cell cultures of RPE and Müller glia will be obtained from adult mice to determine
which Müller glia genes are affected by eye drop application of PNU-282987. Primary Muller glia cells will be
cultured in conditioned media obtained from primary cultures of RPE cells obtained from adult mice that are
treated with PNU-282987. It is hypothesized that PNU-282987 binds to alpha7 nAChRs on retinal pigment
epithelium to release signaling molecules onto Muller glia that induce dedifferentiation. After mRNAseq analysis,
up- or down-regulated genes will be compared with published literature of Müller glia genes involved in
development and dedifferentiation. Identified genes will be quantified and verified with RT-PCR, RNAscope
technology (ACDBio) and immunocytochemistry. Once specific genes are identified and potential pathways are
proposed, gene knockout (KO) studies and gene overexpression studies will be performed in primary Muller glia
using CRISPR technology to demonstrate the necessity of these genes in Muller glia-derived neurogenesis
induced by PNU-282987 in adult mice. The results from this study could have significant implications in the retina
where neurons are lost due to aging or diseases such as glaucoma, macular degeneration or retinitis pigmentosa
and could challenge current ideas that maintain the adult mammalian CNS is incapable of regeneration.

Public health relevance
Irreversible vision loss is one of the top ten disabilities worldwide and is responsible for reduced quality of life and a substantial burden on national healthcare systems. Experiments in this study are designed to test the hypothesis that PNU-282987-induced neurogenesis of retinal neurons in adult mice occurs through activation of Müller glia. The results from this study could have serious implications for reversing vision loss due to traumatic injuries, degenerative retinal disease or age-related issues.